ACTIVE SITE SIGNATURES FOR AUTOMATIC UPDATES OF SFLD SUPERFAMILIES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. major unsolved problem for structure-function linkage using computational prediction is that while we can accurately cluster protein sequences and structures with good statistical significance based on many types of similarity metrics, how those clusters link to functional classes is not clear. Although simple approaches such as ortholog prediction can achieve good results for sequences that are closely similar or that contain readily identifiable motifs that distinguish functional classes, for many protein superfamilies successful prediction is far from trivial. This is the case for the functionally diverse superfamilies in the SFLD. These are homologous sets of enzymes that carry out different chemical transformations, using different substrates, but all share a specific chemical functionality or partial reaction. The main purpose of the SFLD is to aid researchers in the curation of these types of superfamilies, to help in the identification of new members of these superfamilies, and to provide an explicit structure-function mapping for these enzymes. (For more information about mechanistically diverse enzyme superfamilies, see Gerlt &Babbitt, Annual Rev Biochem. 2001, pp. 209-46.) Because the different functional families in a given superfamily look similar but perform different specific reactions, they are difficult to annotate and easy to misannotate, showing levels of misannotation as high as 80% in the archival databases Genbank NR and TrEMBL (Schnoes, Dodevski, and Babbitt, submitted). Because sequence information is still coming available in large volumes, automated methods are required to update the SFLD superfamilies with newly determined sequences and assign them to the appropriate functional families. Clearly, improved methods for achieving these functional assignments are urgently needed. Development of an approach to achieve this has been a major focus of the Babbitt and Ferrin groups in collaboration with the group of Prof. Jacquelyn Fetrow of Wake Forest University.